Exploring the pathophysiology and treatment of LCHADD retinopathy

Project Summary
Progressive retinopathy with vision loss is a unique complication of Long-chain 3-Hydroxyacyl-CoA
Dehydrogenase Deficiency (LCHADD) and mitochondrial Trifunctional Protein Deficiency (TFPD), rare genetic
fatty acid oxidation (FAO) disorders. Gradual macular pigment clumping, followed by progressive deterioration
of the retina occurs in almost all LCHADD patients beginning in childhood and progressing over time. This
manifests initially as decreased night vision, progresses to loss of color vision, and ultimately to decreased
central vision. While early diagnosis through newborn screening and sustained dietary therapy can slow
progression, no successful treatment directed at retinopathy currently exists, and children with LCHADD/TFPD
continue to suffer progressive blindness. Novel treatments for LCHADD-associated retinopathy are needed but
appropriate experimental models have been lacking. We recently created 2 models of LCHADD-retinopathy; a
murine knockin of c.1528G>C, the common mutation in the HADHA gene that causes LCHADD, and cultured
RPE-like cells differentiated from induced pluripotent stem cells (iPSC) derived from patients' fibroblasts.
The pathophysiology of LCHADD-associated retinopathy is not completely understood but begins with
loss of retinal pigment epithelium (RPE). Two potential molecular mechanisms include; energy deficit due to
decreased FAO to support normal RPE functions, or selective toxicity of accumulating partially oxidized fatty
acid metabolites. Children with lower blood concentrations of LCHADD-specific 3-hydroxy-acylcarnitines have
preserved retinal function implying that retinal damage may be mediated through accumulation of toxic fatty
acid intermediates. If so, then gene therapy directed toward a peripheral organ such as muscle or liver could
lower circulating toxic metabolites, prevent retinal degeneration, and address other LCHADD-associated
complications. Alternatively, retinal preservation may require the restoration of LCHAD activity directly in RPE,
and circulating acylcarnitines are simply a marker of partial FAO in the retina. We will use our 2 models of
LCHADD-retinopathy to test which approach will prevent RPE dysfunction and retinal degeneration.
LCHADD-RPE exhibit decreased ability to oxidize palmitate, accumulated acylcarnitines and neutral
lipids, and increased susceptibility to H2O2 oxidative stress in comparison to wild type (WT) RPE. We propose
a series of experiments to test LCHADD-associated RPE alterations such as lipid processing and sensitivity to
H2O2 treatment under different FAO conditions compared to WT RPE. Additionally, the LCHADD-mouse has
decreased visual performance and electroretinogram (ERG) responses compared to WT mice. Our goal is to
characterize the visual acuity, retinal structure and function of LCHADD mice and to test the effects of hepatic
versus retinal directed gene therapy approaches. The outcome of these experiments will expand our
understanding of LCHAD-specific pathology and provide the basis for a translational effort to treat LCHADD
retinopathy, potentially with retinal gene therapy, a new treatment modality of which OHSU is a national leader.

Public health relevance
Project Narrative Progressive retinal disease with vision loss is a chronic complication of long chain 3-hydroxyacyl-CoA dehydrogenase deficiency (LCHADD) with no current treatment and no previously established animal or cell culture models in which to test novel therapies. We have developed 2 novel experimental models and now propose experiments to characterize an in vitro model of LCHADD induced pluripotent stem cell (iPSC)-derived Retinal Pigment Epithelium (RPE)-like cells from patient specific fibroblasts and a novel LCHADD knockin mutant mouse model that exhibits decreased vision. These experiments will further our understanding of LCHADD retinal disease and provide the basis for the development of future treatments for these patients.